Elucidating Context-Specific FERONIA Receptor Kinase Signaling

Elucidating Context-Specific FERONIA Receptor Kinase Signaling
Project Summary/Abstract
Understanding how cellular signaling pathways achieve specificity is an important question in developmental
biology. FERONIA (FER) receptor kinase is universally expressed and a critical regulator in plant growth,
development and stress responses. Loss-of-function fer mutant has pleotropic effects with reduced plant
growth, fertility and altered responses to stress. The goal of the proposal is to understand how FER signaling
achieves specificity using root as a system in genetic model plant Arabidopsis. The primary roots offer both
spatial and temporal information of root development, and our preliminary single cell RNA-sequencing (scRNA-
seq) showed that FER-regulated gene expression in root is high cell type-specific, which makes root an ideal
system to study FER signaling specificity. Multiple lines of evidence indicated that FER phosphorylates
transcription factors to regulate gene expression and various biological processes. First, recent multiomics
study demonstrated that FER regulates the expression of thousands of genes including large number of
transcription factors (TFs), suggesting that transcriptome reprogramming is critical for FER-mediated signaling.
Second, it has been demonstrated that FER phosphorylates transcription factors, MYC2 and ABI5, to regulate
plant immunity and seed germination, respectively. Third, scRNA-seq analysis with fer mutant revealed that
FER affects the expression of ~3,000 genes in roots in a highly cell type- and developmental stage-specific
manner. Fourth, AKS (Abscisic acid-responsive Kinase Substrate) family of TFs are FER kinase substrates.
Further genetic and functional data showed that they are major transcription factors functioning downstream of
FER and FER is required for their transcriptional activity. AKS genes have cell type- or developmental stage-
specific expression patterns while FER has a more universal expression, suggesting that FER modulates these
TFs in different cell types in regulating their target gene expression and FER signaling specificity. Based on
these results, it’s hypothesized FER phosphorylates and modulates the AKS TFs in specific cell types and
developmental stages to regulate their target gene expression in achieving FER signaling specificity. scRNA-
seq analysis, tissue-specific gene manipulation by CRISPR/cas9 and complementation, target gene
identifications and transcriptional network analysis are proposed to test the hypothesis. In Research strategy
section1, the genetic, genomic and functional interactions of FER and AKSs will be characterized by
constructing genetic mutants, phosphosite mutations and identifying cell type-specific transcriptional targets. In
Research strategy section 2, scRNA-seq of fer and aks mutants under control and salt treatment will be
performed. In addition to the cell type-specific FER CRISPR knockout mutants we have already successfully
constructed, we will also generate cell type-specific FER complementation lines. Further characterization of the
cell type-specific CRISPR knockouts and complementation lines along with the gene regulatory network
analysis will provide unprecedent new insights into how FER achieves signaling specificity.

Public health relevance
Elucidating Context-Specific FERONIA Receptor Kinase Signaling Project Narrative The proposed studies will provide unprecedent new insights into how FER receptor kinase achieves signaling specificity. Receptor kinases signaling pathways play critical roles in diverse cellular processes and deregulation of the pathways leads to serious human diseases such as cancer. Understanding the pathway specificity has been a major area of study in developing effective therapies. Better understanding cell signaling specificity of FER receptor kinase can help shed light on receptor kinase signaling pathways related to human health.